Physical-plasma device for catheter-based cardiovascular treatment

Abstract: A physical-plasma catheter for treatment of cardiovascular disease will be optimized, manufactured,
and tested and its effects on S. aureus biofilms associated with infective endocarditis will be evaluated. Infective
endocarditis (IE) is a bacterial infection of the endocardium of the heart or prosthetic implants that has a high
rate of mortality (25 – 30 %) and a high necessity for surgical intervention (50%). Multiple species are potential
causative agents of endocarditis including S. aureus, S. epidermidis, enterococci, and streptococci, but the
leading pathogen is S. aureus. Physical-plasma, an ionized fluid consisting of electrons, ions, and chemically-
reactive neutral and excited species has been demonstrated to have many applications in biomedicine,
particularly related to infection control. Physical-plasma has shown efficacy against a wide range of pathogens
including bacteria, virus, fungi, and spores. In addition, it has also been demonstrated to disrupt protective
biofilms on bacteria. We have previously developed and demonstrated a physical-plasma device that can
produce plasma in biological liquids, killing biofilm-protected S. aureus bacteria without producing bubbles that
would lead to gas embolism in clinical application. Complementary addition of vancomycin further increased the
efficacy. It has also been demonstrated benign on cultured murine endothelial cells and human endothelial cells
(HAEC) under the same treatment conditions. However, this previous work has shown that the spatial effect of
physical-plasma needs to be increased to be an effective intervention. Our hypothesis is that physical-plasma
delivered directly to the site of endocarditis by means of a cardiovascular catheter will reduce mortality and
decrease reoccurrence of the infection. Moreover, it is expected that physical-plasma can be used as a
complementary therapy with antibiotics by disrupting biofilm protection of bacteria and allowing antibiotic
molecules to reach the underlying bacteria. Three specific aims will be pursued to prove this hypothesis: (1)
Integrate an micro-electrode physical-plasma array (MEPPA) and extruded catheter body while optimizing
design and materials for animal trials and future clinical applications; (2) Evaluate physical-plasma efficacy
against biofilms in a dynamic, flowing environment including potential for circulating vegetative bacteria, biofilm
fragmentation, and interaction with complementary antibiotics.; (3) Evaluate the physical plasma catheter for
safety and efficacy in a New Zealand white rabbit model of infective endocarditis. Overall success of these
specific aims will result in the development of a fully-integrated physical-plasma catheter that demonstrates
effective destruction of S. aureus biofilms associated with infective endocarditis, including in an appropriate
animal model. Next steps will include larger animal studies and clinical trials of this ground-breaking technology.

Public health relevance
Project Narrative: Infective endocarditis (IE) is a devastating infection of the endocardium and valves of the heart for which the prognosis is poor (20 – 30% mortality rate) and the eventual intervention usually surgical (50%). Staphylococcus aureus is the most prevalent pathogen, which can display antibiotic resistance as well as protect itself with a biofilm which degrades the efficacy of antibiotic treatments. A novel physical-plasma device, which is effective against biofilms and is not susceptible to treatment-resistance, is a potential future, less-invasive treatment for this disease.